PROJECT MANAGEMENT, TECHNICAL, COMPUTING, AND ADMINISTRATIVE SUPPORT SERVICES FOR THE DIVISION OF CANCER CONTROL AND POPULATION SCIENCES (DCCPS)

The purpose of this requirement is to procure project management, technical, computing, and administrative services on behalf of the Division of Cancer Control and Population Sciences (DCCPS) at the National Cancer Institute (NCI) to support the execution of it’s critical mission, which aims to reduce the risk, incidence, morbidity, and deaths from cancer and to enhance the quality of life for cancer survivors and others affected by cancer.

As part of its recurring, ongoing operations, and to successfully execute its critical mission, the DCCPS requires qualified program management, technical, computing, and administrative services to manage its research portfolios, which primarily include grants related to cancer control and population sciences, the resulting tools, products, and scientific advances.